Novel Thermoelectric Scalp Cooling System for Mitigating Chemotherapy-Induced Alopecia

Abstract
Chemotherapy-induced alopecia (CIA) is a distressing side effect of cancer treatment, affecting approximately
65% of patients, particularly those undergoing taxane- or anthracycline-based therapies for breast and
gynecological cancers. This condition significantly impacts patients’ psychological well-being, especially among
women, leading to anxiety, diminished self-esteem, and reduced quality of life. While scalp cooling (SC) has
proven effective in mitigating CIA, current technologies are hindered by high costs, limited accessibility, patient
discomfort, and inconsistent results across chemotherapy regimens. Additionally, the need for external chillers,
fluid circulation, and frequent cap replacements limits adoption, particularly in resource-limited settings.
This proposal aims to develop and validate a next-generation scalp cooling device using solid-state
thermoelectric cooling technology. Our fluid free and fully portable cap delivers precise, sustained cooling
without external equipment, enhancing patient comfort and mobility. This breakthrough design expands access
to infusion centers, at-home settings, and underserved communities, providing a more effective, affordable,
and patient-friendly solution for CIA prevention. Through clinical validation, we aim to improve the quality of life
for cancer patients receiving chemotherapy, advancing equitable access to this transformative technology.

Public health relevance
Project Narrative Hair loss caused by chemotherapy, otherwise known as chemotherapy induced alopecia, is a common and distressing side effect for many cancer patients, significantly impacting their emotional well-being and quality of life. Scalp cooling that causes blood vessel constriction has been proven to reduce hair loss by reducing the amount of chemotherapy reaching the scalp. Existing scalp cooling methods can be prohibitively expensive, burdensome, uncomfortable, and difficult to access, so we are developing an innovative, lightweight, portable cooling cap using modern solid-state technology designed for comfort and ease of use.